COMPARE INTRA/INTER PATIENT VARIABILITY OF CYCLOSPORIN PHARMACOKINETICS

To evaluate the degree of variability of exposure to cyclosporine between the Neoral and Sandimmune formulations. To determine the relationship between trough levels and the area under the time/whole-blood concentration curve (AUC) for both formulations.